Exploring the role of epileptiform activity in Alzheimer's Disease

PROJECT SUMMARY / ABSTRACT
The candidate is an epileptologist and neuroscientist at the Massachusetts General Hospital
(MGH) and Harvard Medical School, whose long-term career goal is to become an independent-
ly funded translational investigator with expertise at the boundary between epilepsy and the
neurodegenerative diseases. Patients with neurodegenerative diseases are at increased risk of
developing epilepsy, and patients with epilepsy often suffer from cognitive co-morbidities. The
ability to translate the clinical experience, research tools, and intellectual framework from the
field of epilepsy to that of the neurodegenerative diseases, and vice versa, could be a powerful
approach to studying both processes. During the proposed training period, the candidate will
combine her prior training in epilepsy, EEG signal processing, and machine learning, with newly
acquired skills in neuroimaging (functional MRI), biostatistics, and additional clinical exposure to
patients with neurodegenerative diseases. Under the mentorship of Dr. Sydney Cash, an expert
in epilepsy and neurophysiologic signal processing, and the co-mentorship of Dr. Reisa Sperling,
an expert in Alzheimer’s disease (AD) and neuroimaging approaches, the candidate proposes
to: 1) Delineate the spectrum of epileptiform activity in early stages of AD and develop computa-
tional tools to identify this activity; 2) Establish the pathophysiologic mechanisms that underlie
epileptiform activity in AD; and 3) Determine how epileptiform abnormalities are associated with
cognitive trajectories in patients with early stage AD. Visual and computational analysis of 24-
hour scalp EEGs will be integrated with resting-state and task-based fMRI measurements, amy-
loid PET imaging, and longitudinal cognitive testing from subjects with AD, to develop a com-
prehensive understanding of the role of epileptiform abnormalities in early stages of AD. In addi-
tion to the research proposed, the candidate’s career development plan entails rigorous
coursework and seminars, practical hands-on experience, and close guidance from a board of
academic advisors with diverse clinical and scientific expertise. The proposed training will allow
the candidate to establish a clinical and research niche at the boundary between epilepsy and
the neurodegenerative diseases, and to develop a comprehensive toolbox with which to probe
human brain function from the standpoint of neurophysiology, structure, connectivity, and tar-
geted pathology. Collectively, these will form the foundation for a successful career as an inde-
pendent investigator pursuing important clinical and translational research projects to improve
the diagnosis and treatment of patients with epilepsy, neurodegenerative diseases, or both.

Public health relevance
Project Narrative People with Alzheimer’s disease are at increased risk of developing epilepsy, and people with epilepsy commonly suffer from impairments in memory and cognition. Our goals are to better understand the interplay between epilepsy and Alzheimer’s disease, and to determine whether epileptiform activity may be a treatable contributor to cognitive decline in people with Alzheimer’s disease. This has important public health implications, as according to the Alzheimer’s Association, a treatment that slows the rate of progression of Alzheimer’s disease by five-fold would reduce the number of people with severe Alzheimer’s disease from 6.5 million to 1.2 million and reduce Medicare costs by 50% by the year 2050.